Blood-brain barrier dysfunction in Alzheimer's disease: from humans to animal models

Project Summary/Abstract:
Extant literature suggests that damage to the blood-brain barrier (BBB) is intricately involved in the
pathogenesis of Alzheimer's disease and related dementia (ADRD). For example, post-mortem studies
demonstrated that ADRD brain is characterized by the accumulation of blood-derived proteins, degeneration of
BBB-specific cells, and injury of vascular endothelium. However, the relationship of BBB damage to
pathological hallmarks of dementia such as beta-amyloid, tau, and cerebral small vessel disease are not well
understood, particularly in humans. This is primarily attributed to a scarcity of in vivo techniques to evaluate
BBB function. The PI is a leading expert in non-invasive imaging of microvascular function, and his laboratory
has recently developed, optimized, and validated a MRI technique to assess BBB permeability to water
molecules. Our preliminary studies using this novel technique has shown strong evidence that 1) Significant
BBB breakdown can be detected in patients with mild cognitive impairment (MCI) using non-contrast MRI; 2)
the extent of BBB breakdown is associated with amyloid burden; and 3) BBB function can predict cognitive
function, particularly in the memory domain.
The central goal of this application is therefore to capitalize on these technical advances and characterize
BBB breakdown in MCI and early dementia, and to understand its causal relationship to both AD and small
vessel pathology. BBB permeability to three molecules of different sizes, specifically water (molecular weight
18 g/mol), Gadolinium MRI contrast agent (molecular weight 547 g/mol), and albumin (molecular weight 66K
g/mol) will be measured in the same participants. Human patient studies will be paralleled by studies in animal
models so that clinically relevant discoveries can be validated in experimental models. The role of inflammation
in BBB breakdown will also be examined. These relationships will be studied in both cross-sectional and
longitudinal manner. This multi-modality, multi-disciplinary project has three Aims. Aim 1 will examine the
cross-sectional relationship between BBB breakdown, amyloid, tau pathology, small vessel pathology, and
inflammatory markers in 125 elderly participants including cognitively normals, MCI, and early dementia. The
inter-relationships among these variables will be studied in the framework of a mechanistic model. Aim 2 will
conduct a 30-month follow-up of these participants and investigate the longitudinal relationship between BBB
breakdown and progression of AD pathology, small vessel pathology, inflammatory markers, and cognitive
function. Finally, in Aim 3, we will validate the pathological underpinnings of BBB dysfunction in ADRD using
two novel rodent models that our collaborators have developed for AD and small vessel disease, respectively.
These rodent models with relatively pure pathology are expected to reveal more definitive relationships
between BBB breakdown and AD and small vessel pathology.

Public health relevance
Project Narrative Recent evidence suggests that breakdown of the blood-brain barrier (BBB) is an important process in the pathogeneisis of Alzheimer's disease and related dementia (ADRD). However, the relationship between BBB damage and other pathogenic events in ADRD are not clear. This project will use cutting-edge BBB imaging techniques, assays, and animal models to systematically investigate BBB dysfunction in humans and animal models in both cross-sectional and longitudinal settings.